Developing and testing the Opioid Rapid Response System

Abstract
This Phase II SBIR will develop and demonstrate the efficacy of the Opioid Rapid Response System (ORRS) to
improve responses to opioid overdoses. Opioid overdoses exact a tremendous cost in lives and expenditures.
Naloxone has been developed to counteract overdoses; however, the nature of these events requires a rapid
response, a situation that challenges emergency responders in both lightly populated rural areas as well as
densely populated urban communities. Apps now exist with the potential to obviate timing concerns by linking
lay citizen responders to events through the 911 system. One such app, PulsePoint, is already in place in 4,100
communities throughout the U.S. for cardiac events, while two other potential partners, OpiSafe and Brave,
focus on overdoses and have expanding customer bases. Other communities simply distribute naloxone as
widely as possible. Neither naloxone distribution nor the apps can accomplish their goals without effectively
recruiting and training many citizen responders who are both able to administer life-saving naloxone and
confident in their ability to do so. To date, there are no evidence-based programs to accomplish these goals.
This project is designed to develop innovative and effective recruitment and training strategies to fill this gap.
ORRS was based on a pilot project demonstrating that lay citizen responders could utilize the PulsePoint app to
respond to overdose events. In Phase I, we developed an effective recruitment protocol based on identity theory
that uses appeals to individuals (personal identity appeals) and others (communal appeals) and administered it
through multi-modalities. We also developed a prototype of ORRS online training and demonstrated usability
and feasibility through a study in five Indiana counties. In Phase II, ORRS recruitment will be refined to
improve the performance of the social media component, the training platform will be enhanced to focus on
CPR and stigma reduction as well as enhanced engagement, and a national RCT will be conducted in 8
communities. Recruitment and training effects on psychological and behavioral outcomes will be evaluated.
The project has great promise for rapid and wide dissemination through the PulsePoint, OpiSafe, and Brave
Technology Coop networks of communities as well as public health departments. The project has the potential
to develop a model for community responses to similar public health events.

Public health relevance
Project Narrative This Phase II SBIR will complete the development of the Opioid Rapid Response System (ORRS), test its efficacy for opioid overdose response, and prepare it for widespread dissemination. Overdose events require a rapid response, which is often not available through standard emergency procedures. ORRS is a system for recruiting and training citizen responders to reverse overdoses through naloxone administration that capitalizes on widely disseminated medical apps linking responders to these events.